Development of a MT-stabilizing agent for the treatment of tauopathies

PROJECT SUMMARY
A group of neurodegenerative diseases referred to as tauopathies, which includes Alzheimer’s disease
(AD), are characterized by the presence within brain neurons of inclusions comprised of
hyperphosphorylated forms of tau protein. Tau is normally a microtubule (MT)-associated protein that
appears to provide stability to MTs in axons, and excessive phosphorylation of tau in tauopathies
promotes its disengagement from MTs and misfolding into oligomeric and fibrillar structures. This
results in increased MT dynamicity, reduced MT density and altered axonal transport in transgenic (Tg)
mouse tauopathy models, with evidence of similar MT deficits in AD brain that likely contribute to
neurodegeneration. We previously demonstrated that administration of the brain-penetrant MT-
stabilizing natural product, epothilone D (EpoD), to Tg tauopathy mice resulted in dramatic
improvements in several key endpoints, including increased MT density, reduced axonal dystrophy,
diminished tau pathology and a lowering of neuron loss with improved cognitive performance.
Although EpoD progressed to a small Phase 1b clinical trial in AD patients, its future clinical
advancement is uncertain. Thus, there would be considerable value in identifying alternative MT-
stabilizing agents that could undergo more thorough testing in AD and tauopathy patients. Towards
this end, we evaluated additional MT-stabilizing compounds from different classes, with the goal of
identifying alternative and potentially improved candidates for development as disease-modifying
drugs for AD and other tauopathies. This effort led to the identification of a preferred subset of brain-
penetrant MT-stabilizing triazolopyrimidines (TPDs) that compared to EpoD and other MT-stabilizing
natural products, offer notable advantages, including oral bioavailability and easier synthesis. With
NIH/NIA support (U01/AG061173), a systematic exploration of the structure-activity relationships of
TPDs ultimately led to the identification of a structurally novel compound (CNDR-51997) that exhibits
improved MT-stabilizing activity and pharmacokinetic profile. Based on extensive characterization of
this compound, including efficacy testing in two different AD mouse models, we believe that CNDR-
51997 qualifies as a candidate compound for further development. Accordingly, the primary objectives
of this three-year, late-stage U01 proposal are to develop CNDR-51997 through IND-enabling studies
and submit an IND application.

Public health relevance
PROJECT NARRATIVE The overarching goal of this three-year, late-stage U01 proposal is to develop a brain penetrant microtubule-stabilizing triazolopyrimidine (TPD) as a drug candidate for Alzheimer’s disease and related neurodegenerative diseases. As part of this proposal, a selected TPD candidate will be advanced through investigational new drug (IND)-enabling studies with the goal of submitting an IND application to the FDA.